Expanding Access to Care for Marginalized Caregivers through Innovative Methods for Multicultural and Multilingual Adaptation of AI-Based Health Technologies

Project Summary and Relevance
Care for children with chronic conditions impacts 10 million family caregivers, who provide an estimated $100 billion in
unpaid care services in the U.S. annually. This is a significant burden for caregivers physically, mentally, and financially.
The burden of care is particularly prevalent among Latino communities, the largest and fastest-growing minority
population in the U.S. Despite the overwhelming and disproportionate need, the use of supportive healthcare services is
lower among Latino caregivers due to barriers including the lack of accessible and culturally and linguistically appropriate
programs. Those, if available, could reduce the multifaceted caregiving burden, and improve the overall health of the
caregiver and child. Language translations and cultural adaptations have been resource-intensive, and recent technological
advancements in machine learning and AI have the potential to automate labor-intensive work. However, machine
translations, if used without careful intention, also may exacerbate biases and existing inequities for marginalized groups.
This proposal will culturally and linguistically adapt, develop, and pilot test an innovative, accessible, and cost-effective
artificial intelligence (AI)-based intervention currently available for English-speaking caregivers of children with chronic
health conditions - “Caring of Caregivers Online” (COCO) - for Latino family caregivers in Spanish. COCO is an
innovative mobile application with an embedded chatbot leveraging cutting-edge technologies to deliver evidence-based
interventions that were previously limited in terms of their ability to reach caregivers due to resource-intensive
requirements both on the caregiver side and provider side. Our preliminary work, in tandem with evidence from the
research literature about specific intervention components COCO delivers (e.g., daily wellness check-in, symptom
self-monitoring, and problem-solving therapy), point to COCO's potential as a high-impact and scalable tool for
expanding access to care.
The development of an accessible, and culturally and linguistically appropriate intervention has the potential to improve
the health outcomes of Latino family caregivers caring for children with chronic conditions, as well as establish long-term
self-management and caregiving skills. Results from this study will guide future intervention refinement, inform
assessment and recruitment strategies, and provide preliminary efficacy for the design of a full-scale clinical trial. Latino
COCO is an accessible and scalable intervention that addresses a critical clinical gap in supporting family caregivers in
marginalized communities. Through adapting COCO, we will develop novel multicultural and multilingual methods
that can be transferable and have the potential to be applied in adapting other dialog-based health interventions for use
among other culturally and linguistically marginalized populations in a scalable and cost-efficient manner.

Public health relevance
Project Narrative Latino caregivers are among the largest and fastest-growing minority populations in the United States and experience significant caregiving burden and inequitable support. Developing a digital health tool that is accessible, scalable, and culturally and linguistically appropriate has the potential to improve the health of Latino family caregivers caring for children with chronic conditions. This is relevant to the NINR prioritized research lenses of health equity, social determinants of health, prevention and health promotion, and systems and models of care.